Analyzing the function and antibody-mediated inhibition of the malaria vaccine candidate PF3D7_1136200

Project Summary
Malaria remains one of the most significant public health concerns with a substantial proportion of the global
population at risk for disease. In malaria-endemic regions, chronic exposure to the malaria parasite Plasmodium
falciparum leads to the development of antibody responses that confer protection from symptomatic disease.
However, naturally acquired immunity to malaria develops slowly, leaving children susceptible to severe disease
and warranting the development of a highly efficacious malaria vaccine. The only malaria vaccine currently
approved for broad use in malaria-endemic areas has low efficacy and will be insufficient to decrease the burden
of P. falciparum malaria. Because of the challenges in malaria vaccine development, a combination vaccine that
targets multiple parasite stages may be a favorable approach to achieve high vaccine efficacy. Among recently
discovered vaccine candidates for the blood stage, the symptomatic stage of infection targeted by naturally
acquired immunity, the highly conserved and previously uncharacterized P. falciparum protein, PF3D7_1136200
has high potential. Previous studies have shown that antibody responses against PF3D7_1136200 correlate with
protection from symptomatic disease. Despite this strong correlation with protection from disease, little is known
about how antibodies against PF3D7_1136200 inhibit the parasite or what role this protein plays in normal
parasite biology. Our preliminary data suggest that PF3D7_1136200 has low antigenicity during natural infection,
similar to the leading P. falciparum blood stage vaccine candidate PfRh5. However, some malaria-experienced
individuals develop relatively strong antibody responses against the protein and harbor PF3D7_1136200-specific
B cells. Based on previous findings and our preliminary data, we hypothesize that PFD7_1136200 is essential
for parasite invasion and that PF3D7_1136200-specific antibodies are cross-strain reactive and inhibit P.
falciparum growth in vitro. In Specific Aim 1, we aim to characterize PF3D7_1136200-specific antibodies and
determine which regions of the protein are targeted by inhibitory antibodies in an effort to better guide vaccine
design. In Specific Aim 2, we aim to utilize PF3D7_1136200-specific antibodies to determine the localization
and expression of PF3D7_1136200 during the P. falciparum asexual replication cycle. Additionally, we aim to
determine the importance of PF3D7_1136200 through the generation of a drug-inducible PF3D7_1136200
knockdown parasite line and subsequent growth and survival analysis. The data generated from these studies
will elucidate the importance of PF3D7_1136200 in normal P. falciparum biology and identify the domains on
PF3D7_1136200 best suited for targeting via vaccine strategies.

Public health relevance
Project Narrative P. falciparum malaria is a significant cause of morbidity and mortality worldwide. Antibody responses against the highly conserved, uncharacterized P. falciparum protein PF3D7_1136200 are correlated with protection from symptomatic disease. To further explore PF3D7_1136200 as a vaccine candidate, this project will study the role of PF3D7_1136200 in parasite biology and determine which protein domains are the main target of protective immune responses.